Early life metal exposure, the gut microbiome, and neurodevelopment in childhood

PROJECT SUMMARY
I am an environmental epidemiologist and microbiome researcher with a primary research interest in the role of
the human microbiome between environmental exposures and human health, including neurological outcomes.
The goal of this proposal is to obtain training and acquire the skills needed to continue to build my academic
research career by linking early life metal exposure, the gut microbiome and metabolome in childhood, and
neurodevelopmental measures of attention.
For this proposal, I plan to train with an expert team of mentors, collaborators, and advisors with
transdisciplinary expertise in exposomics, exposure biology, neurodevelopment, biostatistics, metabolomics,
epidemiology, and microbiome research. The proposed training plan includes clinical and laboratory rotations,
coursework, seminars and meetings, conferences, and 1-on-1 tutorials with mentors and advisors, covering
research and career development topics. This training will provide skills and knowledge in the areas of
neurodevelopment, and exposomics, including exposure biology and multi-omics analysis. Upon completion of
this training plan, I will be able to achieve my long-term career goal of becoming an independent researcher
focused on the inter-relationships among environmental exposures, the microbiome, and neurodevelopment.
To that end, I propose leveraging the use of the established Programming Research in Obesity, GRowth,
Environment and Social Stressors (PROGRESS) birth cohort, based in Mexico City, and adding microbiome
analysis. Specifically, I will: 1) train with Dr. Arora in exposure biology and analysis of baby teeth as a
biomarker of early life metal exposure; 2) train with Dr. Wright, in collaboration with Dr. Shamesh, in
neurodevelopmental assessment, principals of neurotoxicology, and their use in epidemiologic studies; 3) train
with Dr. Faith in metagenomic analysis, 4) integrate biostatistical assessment of mixtures and high dimensional
data, guided by Dr. Gennings; 4) learn about stool metabolomic analysis methodology with Dr. Walker; 5) work
with Dr. Tellez-Rojo to facilitate stool sample collection and data analysis in PROGRESS. I will use these
training and research activities to integrate the microbiome into an exposomic analysis of neurodevelopment. I
will use the research and career development training I receive to establish myself as an independent
investigator with a tenure track faculty position, able to secure R01 funding.
This research proposal combines innovative measures of exposure, novel data analysis approaches,
and high resolution omics analysis to address gaps in the understanding of timing and potential mechanisms
by which metal exposures, and the gut microbiome and metabolome, are associated with neurodevelopmental
measures of attention. The proposed research and training plan builds the foundation for an independent
research career that aims to clarify the links between environmental exposures and neurodevelopment, via the
human microbiome.

Public health relevance
PROJECT NARRATIVE Studies have shown that early life exposures can influence neurodevelopment, and gut microbiome composition and function, however, studies linking early life environmental metal exposure to the gut microbiome in childhood, and their combined associations with neurodevelopment are lacking. The proposed research will investigate these associations and their timing by integrating early life measures of metal exposure, detailed analysis of the gut microbiome and metabolome, and behavioral and biological measurements of neurodevelopment. Filling these knowledge gaps will provide information to better inform future interventions.